Defining how neonatal hyperoxia causes pulmonary hypertension in adults

PROJECT SUMMARY / ABSTRACT
People born preterm are at risk for developing pulmonary hypertension (PH) and heart failure that will
profoundly shorten their lifespan. This is an emerging epidemic of growing concern because conservative
estimates suggest there are 4 million survivors of preterm birth living in the United States, 40% of which have
subclinical PH. The risk of developing disease is highest in adults born extremely preterm and thus directly
associated with their need for supplemental oxygen (hyperoxia) at birth. But how hyperoxia at birth triggers
disease, and whether PH and heart failure are integrated or separate diseases is not known. We propose to fill
this gap in knowledge using lungs of preterm infants, adults who were born preterm, and an established mouse
model wherein hyperoxia between postnatal days (PND) 0-4 causes PH via three distinct stages. The first or
priming stage occurs when the lung is exposed to hyperoxia. During this time, hyperoxia stimulates endothelial
expression of angiotensin converting enzyme (ACE) responsible for producing the vasoconstrictive peptide
angiotensin (Ang) II and driving PH when uncontrolled. Hyperoxia also suppresses proliferation of
cardiomyocytes lining the pulmonary vein and extending into the left atrium, resulting in left atrial dilation and
insufficient filling of the left ventricle. This is followed by a latency period where ACE and Ang II levels continue
to increase even though the lung is no longer in hyperoxia and the loss of atrial cardiomyocytes causes
progressive diastolic dysfunction. The third or disease stage is characterized by high NADPH oxidase (NOX) 3
in pericytes, vascular remodeling and congestion, and mortality. The high expression of NOX3 in pericytes was
unexpected and may explain why hyperoxia causes post-capillary remodeling, thus distinguishing it from
pulmonary arterial hypertension (PAH) where smooth muscle cells express NOX4. Building off these findings,
we hypothesize neonatal hyperoxia stimulates expression of ACE in pulmonary endothelial cells, which
persists and increases because of ongoing endothelial injury and diastolic dysfunction, and causes PH
when it dysregulates Ang II and NOX3 later in life. We will determine how hyperoxia regulates ACE in
pulmonary endothelial cells (Aim 1), how NOX3 contributes to vascular remodeling (Aim 2), and whether
suppressing ACE/Ang II signaling effectively reduces PH and diastolic dysfunction caused by hyperoxia (Aim 3).
Understanding how hyperoxia causes cardiovascular disease could advance new concepts on how to best
manage it in people born preterm.

Public health relevance
NARRATIVE / RELEVANCE TO PUBLIC HEALTH People who are born preterm have a higher risk of developing pulmonary hypertension (PH) and heart failure as adults than people who are born full term. Molecular and cellular mechanisms that trigger and promote this disease are poorly understood. Since preterm infants are often exposed to supplemental oxygen (hyperoxia), this project seeks to understand how hyperoxia at birth promotes PH in adults and test potential therapeutic interventions that could advance thinking in how to improve the health of people born preterm.